Impact of Environmental Exposures on Lung Immunity over Age

PROJECT SUMMARY/ABSTRACT
Dr. Ural is a Postdoctoral Scientist in Dr. Donna Farber’s lab working on identifying alterations in the immune
system of aging lung and lung-associated lymph nodes. As demographics are changing across many parts of
the world, age related lung diseases are expected to become a major healthcare burden. Recent studies have
shown that lung function starts to decline after third decade of life, and this leads to increased mortality rate in
elderly people due to infectious and non-infectious lung diseases. Human aging is shaped with prolonged
exposure to the environment; however, due to limited availability of healthy pulmonary tissues, the impact of
environmental exposures (e.g., air pollution) to the aging immune system is not well studied.
Macrophages are a diverse population of cells that perform specialized tissue functions. Environmental
exposures such as air pollution can have direct effect on the local immune system and pulmonary macrophages
are among the first cell types to respond to all the environmental exposures for tissue homeostasis and
surveillance. However, macrophage studies in human tissues are very limited due to limited availability of such
tissues. It is important to elucidate how aging pulmonary macrophage immunity changes with environmental
exposures in order to develop effective immune therapies to recently encountered pathogens. Dr. Donna
Farber’s lab has a unique collaboration with a local procurement organization to obtain multiple tissue sites from
healthy brain-dead organ donors. Our studies showed that carbon particulates accumulate in human lung
draining lymph nodes (LLN) with age while the corresponding mesenteric lymph nodes (MLNs) show no
particulate matter. Carbon particulates are contained within a subset of lymph node macrophages, and this leads
to reduced activation and phagocytosis with impaired production of cytokines in this macrophage subset.
Moreover, these alterations in aging LLNs disrupt B cell follicle integrity with reduction in lymphatics, which is not
observed in MLNs. Our central hypothesis is that the environmental particulates are contained within a specific
pulmonary macrophage subset because of its distinct localization and due to these particulates, aging pulmonary
macrophages have altered transcriptional profile, with compromised respiratory immune response. The aims of
this proposal are 1) Evaluate functional properties of human pulmonary macrophage population that takes up
environmental particulates over age. 2) Evaluate the phagocytosis and migration potential of aging pulmonary
macrophages and how macrophages with atmospheric particulate matter respond to recently encountered
pathogens over age. This career award will give Dr. Ural the opportunity to advance her training and experience
on macrophage aging, using innovative approaches such as two-photon imaging, CODEX imaging, and
computational analysis of high dimensional transcriptomics data. This award will comprehensively prepare Dr.
Ural for her future career as an independent pulmonary researcher studying the role of aging in tissue specific
immune regulation.

Public health relevance
PROJECT NARRATIVE Elderly people are more susceptible to respiratory tract infections. Pulmonary macrophages are among the first cell types to respond to all the environmental exposures (e.g., air pollution) and functional discrepancies in this innate immune cell subset can increase the severity of diseases such as influenza due to aggravated inflammation; however, age-associated changes in pulmonary macrophages that are under constant influence of the environment exposures is not well studied. This proposal is designed to investigate the hypothesis that atmospheric particulate matter is contained within the macrophages and due to these particulates, aging pulmonary macrophages have altered transcriptional profile with compromised respiratory immune responses.